Functional consequences of SMARCB1 variants

ABSTRACT
SMARCB1 deficient cancers constitute a growing number of rare and difficult to treat cancers affecting children,
adolescents and young adults. Our clinical assessments of SMARCB1 function rely upon immunohistochemistry
and thus our ability to determine nuances of SMARCB1 function remain limited. Unlike other better characterized
tumor suppressors such as PTEN or TP53, SMARCB1 has been in the cancer biology literature since the 1990s.
More recently, genetic variants of unknown significance in SMARCB1 have been identified across 1% of all
cancers. Despite computational efforts to assign function, we know that members of the SWI/SNF chromatin
remodeling complex such as SMARCB1 have been difficult to assess given the limited structural data available.
To address this gap, we have performed deep mutagenesis scanning of SMARCB1 which enables the
assessment of >99% of genetic mutations across SMARCB1. This proposal now focuses on understanding the
mechanisms behind these genetic changes. Specifically, we will enhance our understanding of key mutations
and residues that are important in SMARCB1’s ability to bind to other SWI/SNF complex members. We will
understand how missense mutations in these key regions lead to oncogenic phenotypes. We will then study the
effects of hyper-functional SMARCB1 missense mutants to further enhance our understanding of the biology of
SMARCB1. Taken together, success of these aims will improve our understanding of these genetic variants of
unknown significance as well as the biology of SMARCB1.

Public health relevance
PROJECT NARRATIVE Variants of unknown significance remain a significant gap in knowledge for many cancer genes. We have performed deep mutational scanning in SMARCB1, a tumor suppressor involved in the SWI/SNF chromatin remodeling complex. We propose to now use this data to provide new insights in SMARCB1 biology with the hopes to translate these findings clinically.